Rocky Mountain Center for Occupational and Enviromental Health

Overall Abstract
The vision of the Rocky Mountain Center for Occupational and Environmental Health (RMCOEH) is to be the
leading center in the world in meeting current and future occupational and environmental health and safety
challenges, thereby protecting workers and their environments. RMCOEH will achieve this through
interdisciplinary education, research, and service, as stated in its mission.
RMCOEH has six established programs that have produced 761 graduates and will continue to support the
center’s goals (Ergonomics & Safety, Industrial Hygiene, Occupational Medicine Residency, Occupational
Injury Prevention Research Training, Targeted Research Training, and Pilot Projects Research Training). The
center’s Continuing Education program, meanwhile, has trained more than 15,000 workers in the preceding
five years and impacts more than 3,000 businesses annually, and our Outreach program touches hundreds of
thousands of people. RMCOEH intends to advance the training and impact of each of these programs,
producing a diverse group of graduates and trainees that is equipped to meet the interdisciplinary needs of
Health and Human Services Region 8 and to carry out the center’s vision and mission.
Further, RMCOEH is proposing the addition of a new graduate certificate program for which there is major
demand in Region 8: Occupational Health Nursing. This program will elevate RMCOEH’s impact to even
greater heights and serve as a pipeline for employers that are in desperate need of occupational health nurses,
ultimately ensuring workers are safer and receive better care in the event of an injury or illness.
RMCOEH’s research efforts currently include 44+ current extramural projects with $30.8M in funding. These
are crucial to the center’s success in the coming grant period. They will continue to bolster the center’s mission
and contribute to the knowledge base of occupational and environmental health and safety issues. An example
of RMCOEH’s ability to perform research that has immediate, real-world impact is its leadership role in
groundbreaking COVID-19 vaccine efficacy studies that provided key information for the pandemic response.
The center’s existing programs, the addition of an Occupational Health Nursing graduate certificate program,
and a continuing focus on research will allow RMCOEH to continue serving a vital role in occupational and
environmental health and safety in Region 8. We are eager to advance our efforts in the coming five years and
aim to make an even larger impact on the lives of workers and their environment.

Public health relevance
Project Narrative RMCOEH’s training, research training, Continuing Education, and Outreach directly align with the mission and goals of the National Institute of Occupational Safety and Health. The center with this application aims to further its significant positive impact on worker health and safety in the Department of Human Health Services’ Region 8 and beyond.